Elucidating anti-angiogenic tyrosine kinase inhibitor-induced vascular dysfunction

PROJECT SUMMARY
Although tyrosine kinase inhibitors (TKIs) are highly potent in treating malignancies, >60% of them have been
reported to lead to adverse cardiovascular outcomes. Moreover, anti-angiogenic TKIs, such as sunitinib,
preferentially induce microvascular toxicity followed by cardiac dysfunction. However, our knowledge of the
underlying pathogenic mechanisms of TKI-induced vascular toxicity (TKI-VT) has been hampered partially by
the limited access to human diseased vascular tissues for molecular and cellular analysis. As such, no effective
strategies have been developed to prevent or treat these otherwise life-threatening cardiovascular complications.
This proposed project will leverage patient-specific induced pluripotent stem cell (iPSC)-derived cardiac pericytes
(PCs) and endothelial cells (ECs) to understand the molecular and cellular basis of TKI-VT and discover
personalized therapies for cancer patients who are suffering TKI-induced cardiovascular disease. In Aim 1, both
monoculture and vessel-on-chip (VoC) coculture systems will be employed to characterize sunitinib-induced cell
type-specific cytotoxicity profiles and aberrant cellular crosstalk between iPSC-PCs and iPSC-ECs that can
contribute to TKI-VT. Overlapping upregulated and downregulated differentially expressed genes (DEGs)
triggered by sunitinib in both cell types will serve as the candidate genes for large-scale druggable target screens.
In Aim 2, CRISPR interference/activation (CRISPRi/a) survival screens will be performed in sunitinib-treated
iPSC-PCs using a customized lentiviral sgRNA library targeting the overlapping DEGs identified in Aim 1. Top
10 hit genes in CRISPRi and CRSIPRa machineries will be subjected to structure-based virtual screens (SBVS)
to discover candidate compounds that can mitigate TKI-VT phenotypes in iPSC-VoCs. In Aim 3, 3D iPSC-
engineered vascular tissues (EVTs) and a mouse model will be used to validate the mitigation efficacy of
candidate compounds on TKI-VT in a more physiological setting. The ex vivo plasma proteome generated from
human whole blood-perfused 3D iPSC-EVTs will be correlated with those identified in patients to discover reliable
disease-relevant biomarkers in predicting individual cancer patients’ susceptibility to TKI-VT. The research and
career development training plans during the K99 phase, under the mentorship of Drs. Wu and Ky, as well as
an expert interdisciplinary advisory committee, will provide Dr. Shen with advanced knowledge in stem cell
biology, vascular biology, cardio-oncology, CRISPR technology, and bioengineering. The development of
CRISPRi/a and SBVS screen platforms (K99) and 3D iPSC-EVTs (R00) will enable him to conduct disease
modeling and drug discovery research in cardio-oncology specifically and vascular disease in general. The new
skills and experience gained during this K99/R00 career development award, combined with Dr. Shen’s prior
expertise in vascular biology, will facilitate his transition to an independent career conducting basic and
translational research in cardio-oncology with a particular focus on the vascular aspect.

Public health relevance
PROJECT NARRATIVE The underlying mechanisms of tyrosine kinase inhibitor-induced vascular toxicity (TKI-VT), an increasingly reported adverse cardiovascular outcome in cancer survivors, are elusive, and preventative or protective treatments are not currently available. Combining patient-specific pluripotent stem cell technology, CRISPR- based high throughput drug screens, physiologically-relevant engineered vascular tissues, and animal models, this proposal seeks to investigate the underlying mechanisms of TKI-VT, which will set the foundation for a more precise search for novel personalized therapeutics for patients manifesting TKI-VT. This proposal will also advance basic and translational research in cardio-oncology by providing a humanized disease modeling and drug discovery platform to study cancer therapy-induced vascular dysfunction in general.